Mechanisms and regulation of mRNA 3' processing

Project summary:
The long-term goal of my research program is to understand, in detail, the mechanisms of
mammalian mRNA 3’ processing and its regulation. mRNA 3’-end formation, typically
involving an endonucleolytic cleavage followed by polyadenylation, is an essential step of
eukaryotic gene expression and it significantly impacts many aspects of RNA metabolism,
including mRNA stability, subcellular localization and translation. In addition, the majority
of eukaryotic genes produce multiple mRNA isoforms with distinct 3’ ends through
alternative polyadenylation (APA). Recent studies have revealed that APA is highly
regulated in development and plays an important role in post-transcriptional gene
regulation. Aberrant APA patterns have been associated with a wide range of diseases,
from cancer to neurological disorders. Key outstanding questions in the mRNA 3’
processing field include: 1) what is the structure-function relationship of the mRNA 3’
processing complex; 2) how is mRNA 3’ processing regulated by cell signaling; 3) how is
APA regulated by RNA-binding proteins? We will address these questions by using
biochemical, structural, and genomic analyses. The results of these studies will not only
provide novel insights into this key step in eukaryotic gene expression, but also pave the
way for developing novel therapy for many diseases.

Public health relevance
Project narrative: mRNA 3’ processing is an essential step in eukaryotic gene expression and alternative polyadenylation is an important mechanism for gene regulation. In this proposal, we will characterize the structure-function relationship of the mRNA 3’ processing complex and the mechanisms by which RNA-binding proteins and post-translational modifications of the core mRNA 3’ processing factors regulate alternative polyadenylation.